Friend-based Intervention to Reduce Alcohol-Involved Sexual Assault Risk

ABSTRACT
Approximately 1 in 5 U.S. college women is sexually assaulted and nearly half of these assaults
involve alcohol. Alcohol-involved sexual assault (AISA) often occurs in social settings, and “bystander”
interventions have been developed to incorporate the social environment into prevention efforts. Friends are
central to the context of SA, as they are often present in social settings where SA risk begins to unfold.
Friends are in an optimal position to identify risk as it emerges, and to take bystander action to prevent
assault. Thus, friends are a logical focus for AISA intervention.
In a Phase I study (R34 AA027046; Read/Livingston), our team completed the development and initial
test of an innovative, friend-based motivational interviewing (FMI) intervention to reduce AISA risk.
Delivered to pairs of friends (dyads) who socialize together, the intervention (Protecting Allies in Risky
Situations; PAIRS) is designed to foster collaborative efforts to increase readiness for, and decrease
barriers to helping behavior, and to plan together for assault prevention skills. In developmental studies
women found our PAIRS FMI to be accessible, practical, empowering, and personally relevant. Our
preliminary data also offered support for the effect of PAIRs on key targets, including readiness to intervene,
decreasing barriers to helping behavior, and increasing friend-based assault protective behavior skills. The
next step is to examine this intervention’s efficacy on a larger scale and against an active control condition.
Accordingly, we now propose to conduct a Phase 2 trial to examine the efficacy of the PAIRS MI with a
treatment-as-usual (TAU) condition, following participants over 1-year post-intervention (Aim 1). This larger
trial also will address some key questions about mechanisms of intervention effects (Aim 2). This includes
examination of target attitudes (readiness, perceived barriers) behaviors (protective behaviors), and the
dyadic relationship as mechanisms of intervention outcome (mediation).
A notable limitation of the extant literature on dyad-based MI is that studies have not taken partner
effects into account. As a result, the complex and sometimes inter-dependent nature of change between
two people who participate in an intervention together is not understood. Accordingly, in this study, we will
examine both independent (i.e., effects of the intervention on each dyad member) and interdependent
intervention effects (effects of the intervention through the partner).
This Phase 2 trial will help to examine the efficacy of an intervention that harnesses the power of
friends to address the significant public health problem of campus-based sexual assault. This study also will
shed needed light on the mechanisms and complex nature of dyadic change that occurs in response to
such an intervention. If successful, findings will lay the groundwork for a Phase 3 intervention trial.

Public health relevance
PROJECT NARRATIVE The proposed Phase 2 trial will test a dyad-based intervention designed to reduce alcohol- involved sexual assault risk in college women. The project also will shed needed light on the ways in which the dyadic relationship may play a key role in intervention outcome, through investigation of the effects of the intervention on dyadic functioning, and how this functioning may influence behavioral risk outcomes. Completion of the study’s aims will result in a unique intervention designed to harness the power of friendships to address the significant public health problem of campus-based sexual assault.